Geroscience Technology Core

ABSTRACT
Despite progress made in understanding mechanisms of aging and how they contribute to healthspan and
age-related diseases, the wider usage of modern technologies among researchers in aging biology is lacking.
However, at the Buck Institute and USC, we have developed and implemented a set of highly integrated and
start-of-the-art platforms (e.g. Mitochondria and Metabolism and Model Organisms Healthspan and Resilience
cores) as well as next-generation and cutting-edge resources (from Single Cell Biology to Artificial
Intelligence). Collectively, these resources are specifically designed for the needs of the biology of aging
scientific community. We propose a user – core interaction that goes deeper than simply analyzing samples; it
is a true collaboration based on advanced knowledge, unpublished studies and up-to-date information on aging
mechanisms. This core derives significance from the rate at which an outside investigator can go from being
unfamiliar with the aging field to preparing competitive grant proposals for consideration at the NIA.